Immunological and Physiological Responses to Measles Vaccine

Measles remains one of the most important causes of child mortality with recent increases in cases
exacerbated by lapses in immunization during the COVID-19 pandemic. Measles virus (MeV) is a highly
infectious non-segmented negative-strand RNA virus. Studies of measles in children and a well-characterized
rhesus macaque model have shown that wild type (WT) MeV infection is initiated in the respiratory tract and
spreads to lymphoid tissue with profound short and long-term effects on the immune system. Measles induces
intense immune activation, increases susceptibility to other infections, decreases Ab to other pathogens, can
trigger autoimmune encephalomyelitis, and induces life-long immunity to MeV. Although infectious virus is
cleared during the rash-associated adaptive immune response, viral RNA persists in peripheral blood
mononuclear cells (PBMCs) and lymphoid tissues for months with ongoing immune stimulation and continued
production of MeV-specific antibody-secreting cells, antibody maturation and multiple waves of functionally
distinct T cells. The live attenuated measles vaccine (LAMV) was developed by passage of WT MeV in chicken
cells, licensed in 1963 and has been remarkably successful in controlling measles. Safety and availability of
reverse genetics has led to development as a vaccine vector and oncolytic agent. However, there is little
knowledge of where LAMV replicates, mechanism(s) of attenuation or how the immune responses induced
differ from WT MeV for protective immunity or immunosuppression except to note that Ab titers are lower and
protection less durable. We have shown that a central difference between infection with LAMV and WT MeV is
replication in immune cells, that antiviral treatment accelerates RNA clearance and impairs antibody
production. We hypothesize that persistent viral RNA is required for stimulation of durable immunity to MeV
and that immune activation in response to infection affects pre-existing immunity. We will address these gaps
in knowledge of LAMV biology through the following specific aims: (1) Identify the viral determinants of
inefficient LAMV replication in immune cells through construction of recombinant LAMVs with WT sequences;
(2) Identify the in vivo sites of LAMV replication and dynamics of RNA clearance compared to WT MeV through
study of MeV replication in rhesus macaques; (3) Define the immune responses to infection with LAMV and
WT MeV and effects of antiviral therapy in rhesus macaques; and (4) Determine the mechanism(s) by which
WT MeV infection decreases Ab diversity in rhesus macaques and whether this occurs after infection with
LAMV.

Public health relevance
Project narrative Measles remains one of the 10 most important causes of infectious disease death due to inadequate population coverage with the live attenuated virus vaccine. The vaccine is safe, effective, and is being modified to produce new vaccines and cancer treatments, but the molecular bases of vaccine attenuation and the biological differences between vaccine and virulent wild type strains of measles virus have never been defined. This project will identify how the attenuated virus differs from wild type measles virus with respect to infection of immune cells, infection of non-human primates, long term effects on the immune system and stimulation of a protective immune response.